Administrative Supplement: The Clinical Genome Resource - Advancing genomic medicine through biocuration and expert assessment of genes and variants at scale

PROJECT SUMMARY/ABSTRACT
This supplement requests funds for the UNC team to host and oversee the 2023 annual
meeting of the NHGRI Division of Genomic Medicine meeting (GM XVI), planned and conducted
by the Advisory Council’s Genomic Medicine Working Group. These meetings have historically
addressed timely topics in genomic medicine to identify research directions for the field and for
NHGRI. The focus of the 2024 meeting will be on genomics and infectious diseases, with
meeting objectives aligned with assessing the current state of the science, determining the key
challenges and opportunities, and outlining a research agenda. The UNC ClinGen grant is well-
suited to help plan this meeting given our close relationship and subcontract with the American
College of Medical Genetics and Genomics (ACMG), through which we have coordinated
dozens of in-person, virtual, and hybrid Steering Committee meetings and in-person meetings
between members of ClinGen’s Clinical Domain Working Groups and Expert Panels.

Public health relevance
PROJECT NARRATIVE UNC was asked by NHGRI leadership to request supplemental funds to cover the planning and execution of the Genomic Medicine XV Meeting, sponsored by the NHGRI and hosted in-person in the Washington, DC area tentatively scheduled over two days in December, 2024.